Proteomic and Functional Analysis of Presynaptic Physiology and Plasticity

ABSTRACT
The molecular mechanisms of plasticity within the presynapse and its role in behaviors such as learning and
memory are still poorly understood, mainly due to a lack of knowledge of the signaling molecules of the
presynaptic cytomatrix and tools to spatially and temporally manipulate presynaptic plasticity. This gap in
knowledge is a fundamental barrier to the field. In this project, we will develop and utilize innovative proteomic,
genome editing, and optogenetic approaches to solve these problems, revealing the proteins and inner workings
of the cytomatrix of presynapses from distinct neuronal cell types and their roles in learning and memory. We
anticipate these data will provide a new and unparalleled molecular framework for future studies on presynaptic
physiology as well as insights into how forms of presynaptic plasticity modulate behavior.

Public health relevance
RELEVANCE The goal of this project is to analyze the cell-type specific proteomes of presynaptic terminals and analyze how specific actin modulatory pathways within govern transmitter release and plasticity. In particular this grant focuses on the roles of Trio, a Rho-family GEF strongly implicated in human brain disorders. Uncovering these molecular mechanisms of presynaptic physiology can be expected to lead to better insights of disorder etiology and potential therapeutic approaches- both major goals of the NIH.